Preclinical Models Core (Core A)

PROJECT SUMMARY – PRECLINICAL MODELS CORE
The Preclinical Models Core (PMC) will provide access to state-of-the art tools and services, education and
training programs and develop new methodologies focused on the discovery and early validation of therapeutic
targets for kidney diseases. Despite recent breakthroughs that have led to major advances in our
understanding of the pathogenesis of kidney diseases such as polycystic kidney disease and focal segmental
glomerulosclerosis, new therapies to diagnose, manage and cure these disorders have been slow to emerge.
A key step in the path to provide new treatments for kidney patients is the availability of sophisticated
preclinical model systems for basic discovery research, interrogation of newly identified pathways and early
target validation. In the PMC, we will exploit the extensive experience and technical expertise of our talented
kidney investigators while leveraging substantial Northwestern resources and bring them together under one
administrative umbrella to establish and provide easy access to: 1) NUmousekidney housing over 50 unique
genetic kidney disease mouse strains 2) a genome editing `concierge' service to rapidly design and generate
new genetic renal models 3) non-genetic kidney disease models including hypertensive and renal
transplantation models and state-of-the art mouse phenotyping services and 4) service for the generation and
genomic editing of induced pluripotent stem cells (iPSC) from patients with kidney diseases and an iPSCkidney
biobank. The PMC Core will also provide hands-on workshops and web-based training in mouse genetics,
genome editing, induced pluripotent stem cell (iPSC) technologies and phenotyping to kidney investigators and
trainees. Outreach and access to all Core-related services will be provided to the global kidney community
through an online web portal named nephro-HUB. Seamless integration and strong synergy with the
Therapeutics Development and Clinical Translation NU-GoKIDNEY Cores, the Pilot and Feasibility and
Enrichment Programs and an innovative Kidney Cure Accelerator program will catalyse discoveries and
accelerate their translation into innovative therapies for kidney patients.